Explore the Comparative Biology on Effects of Skin Ulceration on AD-Pathological Neurodegeneration

Abstract
This application is in response to NIH PA-20-272 Administrative Supplements to Existing NIH Grants and
Cooperative Agreements (Parent Admin Supp Clinical Trial Optional) https://grants.nih.gov/grants/guide/pa-
files/PA-20-272.html. After our -80C freezer completely stopped working and was then removed due to the
severe damage caused by Hurricane Ida power outage, we are running of -80C storage space for our samples
of the parent 1R21AG068756. This supplement request is to obtain supplement funding for the purchase of a
replacement of this -80C freezer (please see attached email).

Public health relevance
PROJECT NARRATIVE Many aged Americans who suffer from Alzheimer’s disease (AD) also suffer from chronic skin ulcers. However, the effects of chronic skin ulceration on AD pathogenesis are poorly understood, leaving a gap in our knowledge, and limiting the development of strategies to mitigate the potential risk of chronic skin ulcers in AD pathogenesis in the elderly. Our comparative biology approaches using both mouse and rat models of AD will provide valuable insights into evolutionarily conserved pro-resolving molecular pathways that prevent and mitigate the risk imposed by chronic skin ulceration on AD-pathological neurodegeneration.